High-fidelity brain perfusion MRI in newborns less than one week of age

Project Summary/Abstract: Cerebral perfusion can now be measured in patients of virtually all ages. Across
the lifespan, the only remaining challenge is the measurement of cerebral perfusion during the first week after
birth, the early neonatal period. Newborns 0-7 days of age have a brain size of approximately one-third of the
adult and cerebral blood flow (CBF) that is as low as 10% of the adult values, making imaging perfusion in
these patients particularly challenging. On the other hand, the first few weeks after birth is the most vulnerable
period in one’s life, with 2.3 million newborns dying in 2022. Both preterm and full-term neonates can suffer
from a number of pathological conditions related to abnormal cerebral perfusion, such as hypoxic-ischemic
encephalopathy, perinatal ischemic stroke, and congenital heart disease. Therefore, there is an urgent need to
develop a clinically feasible perfusion imaging technique for the early neonatal period.
Some perfusion techniques involve exogenous tracer, thus are less desirable for use in neonates. ASL MRI
is an excellent noninvasive tool to study cerebral perfusion in neonates, because it does not require exogenous
agents, can be repeated multiple times, and allows quantitative measurements. However, the low intrinsic SNR
and presence of several confounding factors have currently limited the use of ASL MRI in neonates.
To the best of our knowledge, no studies have conducted systematic development of ASL perfusion MRI in
healthy neonates. One of the main reasons is that, unlike conducting technical studies in adults, enrollment
and access to healthy neonates for technical studies is extremely challenging. As a result, the vast majority of
ASL studies on neonates have been conducted as an add-on to clinical MRI scans, on neonates who have
certain clinical indications (to require them to receive an MRI). A novel aspect of the present application is that
we will leverage unique resources at our institution that allow us to recruit healthy early neonates for research-
dedicated MRI, which provides the necessary scan time to conduct systematic sequence development studies.
Therefore, the primary goal of this application is to develop non-invasive ASL MRI for perfusion imaging in
early neonates (<1 week after birth). This project consists of two aims, a technical aim and an initial application
aim. Aim 1 will develop non-invasive perfusion MRI techniques in healthy neonates, which is in turn divided
into four sub-aims covering distinctive components of the technical development. These components include
MRI pulse sequence and acquisition development, expansion of the sequence to multiple post-labeling delay
(PLD) scheme, on-scanner processing and kinetic modeling of the MRI data, and development of a toolbox for
automatic and standardized quantification of perfusion parameters. Aim 2 will conduct a feasibility study to
evaluate the clinical utility of perfusion MRI in neonates with hypoxic ischemic encephalopathy (HIE).
Upon the successful completion of this project, we will have developed a reliable and turnkey perfusion
imaging technique that is ready for broad use in both clinical and research settings.

Public health relevance
Project Narrative Brain blood supply is a critical indictor of newborn’s brain health. However, at present, there is a scarcity of non-invasive imaging tools that are available to clinicians and researchers to evalute blood supply to newborn baby’s brain. The present project will develop a set of image acquistion, processing, and analysis tools for reliable and turnkey assessment of blood flow in newborns less than one week of age.